Cryptococcal Nanotherapy: Engineering a Novel Fungus-Based Platform for Improved Drug Delivery to the Central Nervous System

Title: Cryptococcal Nanotherapy: Engineering a Novel Fungus-Based Platform for Improved Drug Delivery to
the Central Nervous System
PROJECT SUMMARY/ABSTRACT
Neurodegenerative diseases affect more than 1.2 billion people worldwide and this figure is steadily increasing.
The exact causes of neurodegenerative diseases are still not entirely understood and the FDA-approved options
for such diseases, especially amyotrophic lateral sclerosis (ALS), have very minimal effects on disease
progression. This limited efficacy can also be attributed to the physiological barriers of the central nervous system
(CNS), the physicochemical properties of the drugs, and the lack of understanding of how the drugs impact ALS.
Riluzole and Edaravone, two FDA-approved drugs for ALS, possess the ideal properties for penetrating the CNS.
However, their mechanisms of action in ALS remain unclear, they are likely to be absorbed by off-target tissues
and can be ejected from the CNS barriers after ALS onset. Resveratrol has been cited as a potential alternative
to existing therapeutics for ALS after demonstrating neuroprotective properties in preclinical animal models of
ALS and is currently being investigated in clinical trials. Resveratrol is a polyphenolic molecule that scavenges
reactive oxygen species and reduces oxidative stress in neuronal mitochondria, two hallmarks of ALS. Like
Riluzole and Edaravone, resveratrol experiences off-target tissue absorption. The drug delivery field has sought
to address this challenge by encapsulating resveratrol with nanomaterials. Despite some success, the nanoscale
formulations of resveratrol are still limited by physiological barriers and the body's clearance mechanisms.
Therefore, there is a critical need for a drug delivery platform that can withstand the body's clearance
mechanisms and bypass the physiological barriers of the central nervous system to enhance ALS treatment.
This work proposes using the neurotropic fungus Cryptococcus neoformans (Cn) to facilitate more efficient
delivery of resveratrol into the central nervous system to treat ALS. Cn is well-equipped to traverse the
physiological barriers of the central nervous system by “professionally” executing three separate mechanisms to
penetrate the tissue: (1) paracellular transport (2) transcellular transport (3) immune cell hitchhiking and
subsequent vomocytosis. Vomocytosis is a process by which Cn liberates itself from the intracellular environment
of phagocytes to promote its survival. Given these unique characteristics, Cn is an ideal candidate for
engineering the desired drug delivery platform as it can bypass physiological barriers to penetrate the CNS and
escape premature degradation by the immune system. The overall hypothesis is that by tethering nanoparticle-
loaded resveratrol onto the surface of Cn we can improve resveratrol delivery to the CNS and modulate ALS
disease progression more effectively. To address this hypothesis, the first aim will optimize the synthesis of fungal
drug carriers (FDCs) and assess their functionality in vitro. The second aim will evaluate the biodistribution of
FDCs, quantify the bioavailability of resveratrol in the CNS, and investigate the therapeutic efficacy of the FDCs
in a preclinical ALS model. A more efficient drug delivery platform that more effectively traffics resveratrol to the
CNS will not only enhance the ALS treatment but also enhance treatment for other neurodegenerative diseases.

Public health relevance
PROJECT NARRATIVE Neurodegenerative diseases, including amyotrophic lateral sclerosis (ALS), affect a significant fraction of the global population; however, FDA-approved options are minimally effective and are greatly limited by the physiological barriers of the central nervous system. The proposed research aims to overcome these barriers by developing a novel drug delivery platform that leverages the neurotropic nature of Cryptococcus neoformans to treat ALS. This technology has the potential to overcome the physiological barriers of the central nervous system, facilitate improved drug delivery, and enhance not only ALS treatment and patient outcomes but also other neurodegenerative diseases.